The Role of Notch Signaling in Shh-mediated Oligodendrocyte Fate Specification

PROJECT SUMMARY
Oligodendrocytes are glial cells in the central nervous system that form myelin, which are critical for the proper
formation and function of neural circuits. During brain development, neural progenitor cells first give rise to
excitatory neurons before gradually transitioning to the production of oligodendrocyte precursor cells (OPCs); a
phenomenon known as the “neuron-glia switch”. Whereas oligodendrocyte differentiation from OPCs and myelin
formation are well understood, we still do not know the earlier mechanisms that facilitate the neuron-glia switch
and specify progenitors towards an OPC fate. This study aims to understand the developmental and molecular
mechanisms that instruct neural progenitors to generate OPCs instead of neurons in the developing mouse
neocortex. Our lab previously identified Sonic hedgehog (Shh) as a critical extracellular signal that initiates the
neuron-glia switch during late embryonic development. However, while some progenitors generate OPCs in
response to Shh, others continue to produce neurons. This suggests that co-existing neural progenitors
differentially respond to Shh and require additional cell-intrinsic mechanisms to acquire an OPC fate. Our single
cell RNA-sequencing analysis and my preliminary data indicate that both the Notch signaling pathway and the
transcription factor Ascl1 are critical for promoting OPC specification from neural progenitors in response to Shh.
Importantly, Ascl1 has recently been identified as a pioneer transcription factor capable of promoting chromatin
accessibility to direct cell fates. Based on these data, I hypothesize that the Notch signaling pathway promotes
OPC specification by regulating the response of neural progenitors to Shh in addition to establishing an
epigenetic state primed for the OPC fate through Ascl1. I will test this hypothesis in two Specific Aims: 1) Define
the functional role of Notch signaling in Shh-mediated OPC specification using in vivo genetic manipulations and
ex vivo pharmacological approaches and 2) Test the hypothesis that Notch signaling cooperates with Ascl1 to
promote an epigenetic state for specifying the oligodendrocyte lineage. Completion of these aims will significantly
contribute to a better understanding of neural cell fate specification and oligodendrocyte development, which will
allow for novel tools and methods to restore myelin following disease and injury.

Public health relevance
PROJECT NARRATIVE During brain development, neural progenitor cells generate a diverse array of cell types, including oligodendrocytes, the myelinating glial cell type of the central nervous system. The purpose of this research is to use the mouse embryonic neocortex as a system to understand the cell signaling pathways and epigenetic mechanisms that specify neural progenitors towards an oligodendrocyte fate. Completion of this work will significantly contribute to a better understanding of oligodendrocyte development and provide insight on novel therapeutic strategies to treat diseases associated with oligodendrocyte dysfunction and demyelination, such as multiple sclerosis, leukodystrophies, and many peripheral pathologies.